Novel role of ROCK2 in Immune Mechanisms of Takotsubo Cardiomyopathy

Takotsubo Cardiomyopathy (TCM) is an acute, life-threatening condition triggered by an intense physical or
emotional stressor and characterized by cardiac dysfunction, apical ballooning of the left ventricle, and thinning
of the ventricular wall. With maximal medical care, patients may recover, but they often live with permanent
sequelae. Patients who have experienced an episode of TCM are at increased risk of an additional episode,
increased risk of additional cardiovascular events, and reduced life expectancy. Importantly, there are no
current formal recommendations for treatment or patient care post-TCM episode. Recent studies have
demonstrated that TCM is associated with a robust immune response in both human patients and in preclinical
rodent models, particularly an infiltration of macrophages into the cardiac tissue. In a similar manner, immune
activation has been demonstrated to play a causal role in preclinical models of hypertension, or an elevation in
blood pressure. Our laboratory has particular expertise in interrogating the immune contribution to hypertensive
pathology and recently demonstrated a role for macrophages in hypertensive heart failure. My preliminary data
confirm that mice treated with isoproterenol (ISO), a catecholamine that mimics the intense the stress
response that occurs in the human condition, develop TCM with macrophage infiltration into the heart.
Furthermore, I have found that the expression of the enzyme ROCK2 (Rho associate coiled-coil containing
protein kinase 2), is elevated in left ventricle of these mice, concurrent with the observed increase in
macrophages. Inhibition of ROCK2 using the novel pharmaceutical KD025 (Belumosudil) prevented the full
development of TCM in mice. I have also found that KD025 treatment halts the progression of hypertension-
induced cardiac fibrosis and in vitro, KD025 attenuates macrophage activation. Lastly, I have found that mice
who have experienced an episode of TCM have a potentiated hypertensive response to low dose Angiotensin
II (Ang II). These recent studies and my preliminary data lead me to the hypothesis that ROCK2 in
macrophages promotes cardiac dysfunction in the acute phase of TCM and contributes to the elevated
cardiovascular risk after a TCM episode. To test this hypothesis, I will use models of TCM and
hypertension, cell culture, and transcriptomics to: Aim1 (K99): Determine the role of ROCK2 in
isoproterenol-induced macrophage activation in TCM and Aim 2 (R00): Determine the mechanisms by
which a history of TCM potentiates future hypertension through reprogramming of myeloid cells.
During the K99 phase, I will receive training in RNA sequencing analysis, immune training assays, and
assessing cardiac remodeling. Determining how ROCK2 contributes to TCM and whether ROCK2 contributes
to increased cardiovascular risk post-TCM will greatly advance the field and result in new therapeutic
opportunities. These proposed studies, along with my proposed career development plan, will provide a
foundation for my career as an independent investigator in an outstanding environment.

Public health relevance
Takotsubo Cardiomyopathy is a life-threatening condition with increasing prevalence and associated with increased cardiovascular risk after a Takotsubo event. Takotsubo is associated with a robust immune response, a common feature with hypertension, the leading modifiable risk factor for cardiovascular disease. These studies aim to determine the mechanisms by with the enzyme ROCK2 functions in myeloid cells to promote cardiac dysfunction in Takotsubo and how it may promote post-Takotsubo cardiovascular risk in order to identify novel therapeutic strategies.